Resident Services Coordination to Support Aging in Place in Affordable Housing for Persons with Alzheimer's Disease and Related Dementias

PROJECT SUMMARY – PROJECT 2
One quarter of the 2.9 million older people living in government-subsidized affordable housing in the U.S. have
claims-based evidence of ADRD. Resident services coordinators (RSCs) are staff assigned to subsidized
housing who manage and provide access to necessary supportive services in the community, provide case
management services, develop programs and assets that support wellness, and address social determinants
that would otherwise undermine successful aging in place. While myriad state and federal policies mandate
and/or incentivize affordable housing building upgrades that address hazardous building conditions, standard
financial models for affordable housing make funding for RSCs extremely challenging and fewer than half of
federally funded properties serving older persons currently have an RSC. This is counterintuitive since
evidence suggests that RSCs are valuable assets to both residents and property owners, benefiting occupancy
and rent collection and reducing evictions and maintenance costs. A HUD survey of property managers found
that they strongly believe RSC’s improve residents’ quality of life, promote independent living, and prevent
unnecessary institutionalization. Little is known about the influence of RSCs on the health and well-being of
residents with ADRD. Using linked data from the AASC (American Association of Service Coordinators), HUD
(U.S. Department of Housing and Urban Development), CMS (Centers for Medicare and Medicaid Services),
and semi-structured interviews with purposively sampled RSCs, we will explore the effects of RSCs on
utilization of services and outcomes for older residents with ADRD using a sequential mixed-methods
explanatory design. Our specific aims are: Aim 1. Compare the effects of RSCs on disparities in use of health
services for residents with and without ADRD; Aim 2. Evaluate the effects of RSCs on inequality in use of
services promoting aging in place for residents with and without ADRD; and Aim 3. Further explore the
barriers and facilitators (including implicit and explicit biases) to aging in place for residents with and without
ADRD that are identified in the first two aims.